Determining the role of macrophages in the developing cardiac conduction system

PROJECT SUMMARY/ABSTRACT
Macrophages are well-characterized as sentinel immune cells that coordinate cellular responses to injury
and infection. However, emerging evidence demonstrates that macrophages have novel, non-canonical
functions critical for developmental regulation, tissue homeostasis, and regeneration. Likewise, cardiac
macrophages have essential functions in patterning the coronary vasculature, valvular remodeling, and in
modulating adult heart conduction. Considering the substantial morbidity and economic burden associated with
abnormal cardiogenesis and arrhythmias, further elucidating the roles of cardiac macrophages in normal heart
development and function is critical for devising novel therapeutic strategies.
In adult mammalian hearts, macrophages electrically couple to cardiomyocytes at the atrioventricular node
via Connexin 43, a gap junction protein. These macrophages directly modulate electrical activity of nodal
cardiomyocytes, and thus cardiac conduction. However, it is not known if macrophages (1) are required during
embryogenesis to establish proper conduction or (2) if macrophage-derived signals modulate heart function in
the developing heart. Therefore, this proposal will address a critical knowledge gap in the field of cardiac
development in two aims. In Aim 1, I will establish the electrical potential of embryonic macrophages to modulate
fetal cardiac conduction. In Aim 2, I will determine how loss of embryonic macrophage affects conduction and
adult heart health. In my approach, I utilize zebrafish, a well-established developmental model whose salient
features include rapid ex vivo development, optical transparency, and high amenability to genetic manipulation.
This proposal will be carried out at Brown University, an exemplar academic research institution with extensive
access to advanced instrumentation. With the guidance and mentorship of her sponsor, Dr. Jessica Plavicki, and
co-sponsor, Dr. Chris Moore, the applicant is prepared and equipped to carryout this fellowship.
My exciting preliminary data reveal previously undescribed roles of macrophages in embryonic cardiac
conduction and cardiogenesis. Using transgenic zebrafish with macrophage-specific expression of a genetically
encoded calcium indicator, GCaMP6s, I found that seeded macrophages have synchronous bursts of calcium
activity in time with ventricular beating. In optogenetic experiments, I show that larval heart rate can be modulated
by stimulating or silencing macrophage electrical activity via macrophage-specific expression of light-gated ion
channels. This poses an intriguing question of whether developmental arrythmias could be corrected by
specifically targeting macrophages. Loss of embryonic macrophages, via drug-inducible ablation or in embryonic
macrophage mutants, altered ventricular chamber formation and function in embryonic zebrafish, as well as adult
cardiomyocyte compaction and gross heart morphology. Successful completion of this fellowship will clarify and
expand our knowledge of non-canonical macrophage functions in the developing heart, as well as provide
valuable insight into the cell types modulating embryonic heart function.

Public health relevance
PROJECT NARRATIVE Heart arrhythmias remain a serious, economically taxing medical concern with substantial morbidity due to their complex underlying physiology. The proposed project establishes the roles of embryonic macrophages in the development and function of the fetal heart conduction system. The identification of a new role for macrophage in cardiac development not only expands our understanding of why arrythmias occur, but also allows for the development of a novel therapeutic target for treating heart dysfunction.